Signals and mechanical forces controlling radial gut morphogenesis

PROJECT SUMMARY/ABSTRACT
The midgut is characterized by a series of concentric, mesodermally-derived layers of smooth muscle
and mucosa, surrounding an inner, endodermally-derived epithelium. In the mature gut, this epithelium forms
finger-like projections extending into the lumen, called villi. In the developing chick, intestinal villi are generated
in a step-wise manner, through a series of epithelial buckling events. Buckling forces are generated through
the confined growth of the epithelium at a time when expansion is restricted by the adjacent differentiating
smooth muscle. The physical constraint experienced by the epithelium changes over time as different layers of
smooth muscle are established sequentially. The location of these smooth muscle layers is established
through the activity of gradients of Shh and Bmp, which, respectively, have positive and negative effects on
smooth muscle differentiation. As they form, the orientation of the fibers in each muscle layer depends upon
the mechanical environment of the gut at the time the layer undergoes differentiation. In spite of this general
outline of how the midgut architecture is established, there is a dearth of information regarding the tissue-level
construction of the other gut segments. Both the foregut and the hindgut arise from the same linear primative
gut tube as the midgut, and have the same general concentric organization. However, there are significant
differences in the thickness and timing of smooth muscle differentiation in the different gut segments, and the
epithelial lining differs dramatically in the three segments. In Aim 1, the mechanisms responsible for the distinct
characteristics of the muscle layers in the fore- and hindgut will be elucidated. The signaling systems known to
be responsible for defining the location and thickness of the smooth muscle in the midgut will be examined in
the fore- and hindgut segments qualitatively (by in situ hybridization) as well as quantitatively (by qPCR) to
determine how they differ in expression from the midgut. These signals will be manipulated by electoration in
vivo and through culturing with agonists and antagonists in explant culture and utilizing tissue recombination to
test their roles functionally. Experiments in Aim 2 will determine the extent to which these differences in smooth
muscle architecture and dynamics are responsible for the distinct epithelial morphology of the fore-and hind
guts. Drugs will be employed to block smooth muscle differentiation to test their necessity. Morphometric and
biophysical parameters will be measured and entered into computational models to test the degree to which
epithelial morphology can be entirely explained on this basis. Finally, in Aim 3 we will assess how transcription
factors of the Hox and paraHox clusters, known to specify regional identity within the gut, alter the molecular
and physical parameters that differentiate the fore-, mid- and hindgut, thereby connecting regional patterning to
morphogenesis of the gut. To that end, transcription fctors involved in regional identity will be misexpressed
ustilizing retroviral vectors, and changes in biochemical and mechanical parameters will be examined.

Public health relevance
PROJECT NARRATIVE Defects in gut formation lead to serious birth defects. This study will shed light on how the digestive tract attains its proper shap and structure, allowing it to perform its key functions in absorbing nutrients.